METABOLIC STUDIES--MUSCLE PROTEIN SYNTHESIS IN NEUROMUSCULAR DISEASE

These studies utilize C13-leucine infusions along with muscle biopsies to evaluate isotope enrichment in muscle protein, serum ketoisocaproatic and exhaled carbon dioxide. To assess the rate of muscle protein breakdown, urinary 3-methylhistidine will be measured. This protocol has now been terminated.